Outer Membrane Vesicles (OMVs) and Proteomics

ABSTRACT
The overall objective of the Outer Membrane Vesicles (OMVs) and Proteomics Core (Core B) is to provide a
centralized platform for standardized OMV preparations; highly pure antigens; and proteomics and bioinformatics
analyses to enhance the activities of the Gonorrhea Vaccine Research Center (GV CRC). Core B is a pivotal
integrative component of the GV CRC and will provide services for all four research projects and the Host
Response Monitoring Core (Core C). To successfully accomplish the goals of Core B, centralized assays have
been divided into four specific aims: 1) Provide OMVs: We will provide large quantities of standardized, naturally
elaborated and extracted OMVs for uniform vaccination studies in all projects. We will ensure the high quality
and consistency of all OMVs by using optimized growth conditions, subcellular fractionation, transmission
electron microscopy, and immunoblotting with an inclusive array of 20 different antibodies against protein
markers developed by the Sikora Lab; 2) Purify Antigens: We will provide pure and intact antigens, with native
conformation preserved, using high quality reagents to ensure consistent experiments; 3) Conduct Proteomics
for Gonorrhea Vaccines: We will conduct subcellular fractionation, sample preparation and processing, high-
throughput quantitative proteomics, and immunoproteomics studies for comprehensive antigen mining and to
define OMV contents; 4) Employ a Comprehensive Bioinformatics Platform. We will provide antigen epitope
mining and extensive analyses of proteomics datasets for all projects by applying wide-ranging downstream
bioinformatics investigations. We will also prepare the datasets for submission and deposit the data to publicly
available databases.
Core B is exceedingly beneficial to the GV CRC as it enables consistent studies between different laboratories
and enhances research progress in an efficient and cost-effective manner.